A novel, pleiotropic oral drug class that inhibits gut migration of activated T cells

ABSTRACT
Inflammatory bowel disease (IBD) is a lifelong inflammatory condition of the gut in which modulation of the
immune system is the major therapeutic strategy. However, despite development of novel therapies, including
antibodies to TNF and IL-12/IL-23p40, and inhibitors of T cell gut homing such as vedolizumab and ozanimod,
only 30-50% of patients experience a sustained therapeutic benefit. Orphagen is developing first-in-class specific
small molecule antagonists to the retinoic acid receptor-alpha (RAR) that regulate the induction of both the gut
homing integrin 47 and a second gut homing receptor, CCR9, during T cell activation. Our preliminary data
confirm that inhibition of retinoic acid signaling through RAR is a promising therapeutic approach to IBD. First,
we showed that a probe RAR antagonist significantly improved gut histology in a mouse naïve T cell transfer
colitis model and inhibited 47 expression and accumulation of inflammatory T cells in the colonic lamina
propria of Citrobacter rodentium-infected mice. Second, with a more specific RAR lead antagonist, OR-812, an
orally bioavailable new chemical entity designed at Orphagen, we showed in a mouse model of oral antigen
stimulation that the induction of 47 and CCR9 in activated T cells is almost completely blocked at very low
doses, <0.4 mg/kg; thus, antagonism of RAR by OR-812 potently blocks the induction of two key gut homing
factors simultaneously. Third, OR-812 was well tolerated in a 14-day toxicity study in mice at 30 mg/kg following
significant systemic exposure, indicating a strong safety margin for this new drug class.
Our major objectives are to qualify OR-812 as a candidate for preclinical development, confirming efficacy in a
murine model of colitis, scaling up sufficient compound for safety studies, and executing an exploratory safety
study in a non-rodent species. In Aim 1, we evaluate the efficacy and potency of OR-812 in a mouse naïve T
cell transfer colitis model. In Aim 2, we develop improved methods for synthesis of OR-812 and ultimately
prepare a 500g batch for the non-rodent exploratory safety studies. In Aim 3, we identify a non-rodent species
for in vivo toxicology studies based on in vitro metabolism of OR-812 in comparison to human and confirm
adequate pharmacokinetics and bioavailability in the selected non-rodent species. In Aim 4, we conduct a 7-day
maximum tolerated dose (MTD) safety study in the non-rodent species and, based on this, conduct a 14-day
dose-range finding safety study in non-rodents with extensive assessment of target organ histopathology to
determine the No Observed Adverse Effect Level (NOAEL). The overall goal of these non-GLP safety studies is
to identify potential toxicities and confirm a preliminary safety margin for OR-812 based on the efficacious dose
in a mouse colitis model. These investigations, if satisfactory, would prepare OR-812 for its next stage: regulated
animal safety and chemical manufacturing studies appropriate for submission of an Investigational New Drug
(IND) application to the Food and Drug Administration (FDA) for a novel drug class for treatment of IBD.

Public health relevance
PROJECT NARRATIVE Despite improvements in therapy over the last two decades, up to half of all inflammatory bowel disease (IBD) patients are unable to achieve long-term remission with available drugs. Orphagen proposes to develop a novel inhibitor of retinoic acid signaling that blocks the induction of two gut homing molecules on inflammatory T cells, preventing their accumulation in the intestine. Building on the promising preclinical efficacy and safety profile of potent and selective retinoid antagonists discovered at Orphagen, we aim to develop a first-in-class oral drug to alleviate suffering in IBD patients.